Discovery and mechanisms of biosynthetic enzymes

PROJECT SUMMARY
Biosynthetic pathways are rich in enzymatic transformations that produce structurally
diverse natural products, such as secondary metabolites, modified nucleic acids, and
modified peptides. Discovering and understanding the molecular basis for these
transformations underpins efforts towards development of deep insights into factors that
either belie many disease processes, or their use in development of therapeutic agents.
The focus of the proposed studies will be elucidating the mechanisms of enzymes that
employ radical transformations in effecting complex transformation in the biosynthesis of
ribosomally produced and posttranslationally modified peptides. This application will
make use of biochemical, structural, and spectroscopic techniques to probe the
mechanisms of these enzymes, establish structure-function relationships, and to discover
novel biosynthetic enzymes.

Public health relevance
PROJECT NARRATIVE All organisms produce a bevy of small molecules, many of which are not required for primary metabolic processes but confer selective advantage to the producing organism in complex biological environments. The biosynthetic pathways to these molecules often involve complex enzymatic transformations, which in many cases remain to be discovered. Understanding the biosynthetic pathways to these small molecule natural products is an important step in gleaning their role in physiology, with an ultimate goal of introducing them in the clinic.